Novel Approaches to Capture, Sorting, and Characterization of CNS-Origin Extracellular Vesicles

Novel tools for diagnosis, prognosis, and monitoring of central nervous system (CNS)
diseases are urgently needed. To place the problem in perspective, just one neurodegenerative
disease, Alzheimer’s (AD), is now the sixth-leading cause of death in the United States, places a
burden of nearly half a trillion dollars per year on caregivers and taxpayers, and is expected to double
in prevalence within the next decade. Reliable and interpretable liquid biopsy tests of easily accessed
fluids such as blood would be of high value in the clinic.
Extracellular vesicles (EVs) have recently emerged as important players in pathophysiology of CNS
diseases. Comprising a diversity of double-leaflet membrane-bound particles, EVs have been
reported by several groups including ours to spread proteins implicated in pathogenesis both in vitro
and in vivo. Importantly, EVs from the central nervous system can be found in the periphery,
appearing to transgress the blood brain barrier quite readily. These EVs may provide a non-invasive
window into the health of the CNS and, potentially, specific CNS cell types. Indeed, our collaborator
on this application, D. Kapogiannis, has published multiple biomarker findings obtained from AD
patient blood using a precipitation/immunoaffinity (PIA) approach to enrich neuronal and astrocytic
EVs. Despite this important success, there is now an opportunity to improve on the existing
technique, increasing sensitivity, specificity, and throughput while reducing sample size and hands-on
time. We plan to address this need, using innovative techniques, tools, and approaches to obtain
highly pure antigen-containing populations of CNS-EVs from four main CNS cell types.
We hypothesize firstly (Aims 1 and 2, R21 Phase) that novel developments in EV isolation and
characterization—1) a multiplexed capture/interferometry instrument (ExoView) of nanoView
Diagnostics and 2) a next-generation, multipass-enabled, optically integrated resistive pulse
technology from Electronic BioSciences—offer substantial improvements over the current state-of-
the-field PIA technique at all steps of the workflow, benchmarked with the guidance of our
collaborator and PIA co-developer. Secondly, in the R33 Phase (Aims 3 and 4), we expect to verify
and optimize the sensitivity, specificity, limits of detection, and any sample pre-processing steps.
Using carefully designed spike-ins and mixtures, along with pure EVs from culture of iPSC-derived
cells and cells genomically edited as negative controls, we will confirm the cell of origin of EVs from
multiple biological sources. Specific, detailed milestones are offered for each phase, including the
transition from the proof-of-principle R21 phase into the more expansive R33 validation phase.

Public health relevance
Narrative Extracellular vesicles are small pieces of cells that can transmit proteins, RNAs, and other factors involved in the development diseases. Released by cells of the brain and eventually reaching blood and other biological fluids, extracellular vesicles offer an easily accessed window into brain diseases and other conditions. In this project, we develop new, more sensitive, and easier-to-use technologies and methods to obtain pure populations of brain-derived extracellular vesicles from human blood samples.